Molecular Cytogenetics Core

The Molecular Cytogenetics Core was involved in the following projects: 1. Detection of IgH translocations in lymphoma (DLBCL) cell lines (collaboration with Dr. L. Staudt). 2. Delineation of complex chromosomal rearrangements and identification of IgH translocation partners by FISH mapping in multiple myeloma cell lines, comprehensive metaphase FISH analyses on advanced multiple myeloma tumors and cell lines (collaboration with Dr. M. Kuehl). 3. Delineation of chromosomal rearrangements produced in clones of monocytic leukemia cell line U937 and ovarian carcinoma cell line OVCAR-8 by RAG- and I-SceI- induced breaks (collaboration with Dr. P.Aplan). 4. Detection and delineation of chromosomal rearrangements (by SKY and FISH) generated by a single targeted DNA double strand break in H2AX deficient mouse cell lines (collaboration with Dr. Aplan). 5. Spectral karyotyping of a set of multiple myeloma cell lines and short term cultures, comparison of FISH and SKY data (collaboration with Dr. M. Kuehl and Dr. A. Protopopov). 6. Delineation of complex chromosomal rearrangements in a collection of mesothelioma cell lines (collaboration with Dr. F.Kaye, Dr. G. Klorin and Dr. O Glebov). 7. Pilot study: translocation between TMPRSS2 and ERG loci in prostate cancer cell lines (collaboration with Dr.L.Cao). 8. Pilot study: verification of flow sorted probes by FISH (collaboration with G. Stone) 9. Determination of ongoing rates of structural and numerical chromosomal instability in selected cancer cell lines using SKY and interphase FISH. Cytokinesis-blocking assay is implemented and tested on cancer cell lines to detect outcomes of asymmetrical mitoses (non-disjunction, chromosome or fragment loss, multipolar mitoses, dicentric chromosomes)(collaboration with Dr. G. Klorin and Dr. M.Kuehl)